A novel agent for preventing fatty degeneration of muscles in LGMD2B

Abstract
Muscular dystrophies are grave genetic disorders characterized by muscle wasting and progressive loss of
muscle function. Approximately 250,000 individuals are currently affected by some form of MD in the US.
Although MDs are caused by mutations in different genes, the muscle pathologies patients develop are shared
and manifest as muscle fatty degeneration (FD) through replacement of necrotic muscle fibers by adipose and
fibrotic tissue leading to loss of muscle function. Limb Girdle Muscular Dystrophy 2B (LGMD2B) affects shoulder
and hip muscles first, and results in severe disability and loss of ambulation by a patient’s second or third decade.
There is currently no cure or therapy for LGMD2B since glucocorticoids, which are the standard-of-care for some
types of MD, are not advised for LGMD2B. We propose to develop Advertent Biotherapeutic’s proprietary agent
ADA011, a specific TGF-β1/3 inhibitor, into a therapy that inhibits muscle FD and preserves muscle function in
LGMD2B patients. We identified ADA011 as a potent inhibitor of de novo adipogenesis in vitro and have now
demonstrated that ADA011 inhibits muscle FD and disease progression in a mouse model of LGMD2B (i.e.,
Bla/J mice). In addition, we showed that ADA011 has favorable pharmacokinetics and is safe in mice. In this
Phase 2 proposal we will demonstrate long-term efficacy of ADA011 in Bla/J mice and demonstrate safety in an
IND-enabling study GLP toxicity study in rats.

Public health relevance
PUBLIC RELEVANCE STATEMENT We are developing a novel therapy for limb girdle muscular dystrophy 2B (LGMD2B), a progressive muscle wasting disease without any existing therapy or cure.